Mechanisms Contributing to Pregnancy-induced Cardiac Remodeling

Maternal healthcare in the US continues to rank poorly in comparison to other developed countries. Maternal
mortality rates in US have been increasing yearly, accounting for 23.8 deaths per 100,000 live births in 2020.
Cardiovascular complications are the leading cause of death in pregnant and postpartum women; however, little
is known regarding the underlying factors leading to this increase, which has been hindered by the lack of
knowledge of how the heart responds to normal pregnancy. Despite this, it is known that during pregnancy, the
heart adapts to meet the increased metabolic demands of maternal organs and the growing fetus. This
adaptation is characterized by reversible cardiac growth and ventricular remodeling, which sustain high cardiac
output during the final trimester of pregnancy. Yet, the molecular programs that support the coordinated
remodeling of the maternal heart during and after pregnancy remain unknown. Coordinated changes in
metabolism could be critical to pregnancy-induced cardiac remodeling, as suggested by their importance in other
contexts. For example, increased cardiac ketone body (KB) metabolism prevents cardiac dysfunction and
remodeling in heart failure, and changes in glucose metabolism regulate exercise-induced cardiac growth.
Nevertheless, surprisingly little is known in the context of pregnancy. This knowledge is important because it
could be leveraged to support maternal cardiac health. There is rationale to expect a link between KB metabolism
and cardiac remodeling. To wit, circulating fatty acids and triglycerides are higher during pregnancy; they supply
energy to highly metabolic tissues, and they are used for liver ketogenesis. Indeed, circulating KBs increase
during late pregnancy in humans and are thought to provide alternative fuel sources for the heart. Furthermore,
our data indicate that the KB metabolism enzyme, β-hydroxybutyrate dehydrogenase 1 (Bdh1), is upregulated
in the heart early in pregnancy, followed in late pregnancy by higher levels of circulating KBs and reduced cardiac
glucose catabolism. These findings suggest that KB availability and the capacity of the maternal heart to oxidize
KBs are increased during pregnancy. We hypothesize that higher cardiac KB oxidation during pregnancy may
spare glucose-derived carbon for anabolic pathways to increase the abundance of glucose-derived metabolites
that facilitate cardiac growth. In support of this idea, our preliminary studies show increased glucose-derived
carbon allocation to nucleotides, glycerophospholipids, and amino acids during pregnancy. In this study, we will
test three aims: in Aim 1, we will determine the extent to which KB availability influences cardiac structure and
function during pregnancy; in Aim 2 we will evaluate the impact of cardiac KB utilization on structural and
metabolic remodeling in the maternal heart; and in Aim 3, we will delineate the influence of KB metabolism on
the reversal of pregnancy-induced cardiac remodeling. Knowledge of how cardiac metabolism contributes to
pregnancy-induced cardiac growth will provide a framework for developing interventions to support maternal
cardiac health.

Public health relevance
Project Narrative Pregnancy promotes remarkable changes in maternal metabolism and physiology. To ensure appropriate delivery of oxygen and nutrients to the fetus and maternal organs, the maternal heart undergoes a physiological form of hypertrophy; however, the mechanisms that contribute to this adaptive remodeling are unknown. This project will examine how the maternal heart adapts to the demands of pregnancy, with the goal of understanding how changes in cardiac metabolism influence pregnancy-induced cardiac growth as well as reversal of cardiac growth following pregnancy.